Administration and Management

ADMINISTRATION AND MANAGEMENT – PROJECT SUMMARY
The administration and management of the National Resource for Network Biology is led by the Principal
Investigator and resource director, Dr. Trey Ideker, and leverages the involvement of the Executive Director,
Dr. Alexander Pico, and key staff members to effectively integrate our common efforts across multiple sites.
We have designated personnel for the roles of Outreach Coordinator, Training Coordinator, and
Infrastructure/Software Development. The Administrative Core also manages our very engaged Driving
Biomedical Projects, Technology Partnerships and collaborations, and it interfaces with our External Advisory
Committee, which regularly provides strong advice on directions for technology development and selection of
driving projects. This component has four Specific Aims: [Aim 1] To direct and measure an ambitious
technology research and development plan that maximally advances the field of Network Biology and its
available bioinformatic resources; [Aim 2] To coordinate technology research with driving biology, relevant
technology, and external advice to maintain perspective on rapidly evolving landscape of the Network Biology
field; [Aim 3] To unify the triage, tracking and completion of network biology training and collaboration
requests; and [Aim 4] To orchestrate a comprehensive Sustainability Plan promoting the long-term utility and
relevance of our technologies and community engagement programs. Collectively, the above aims are
effectively met by the established and successful organizational structure of our center.